IGF::OT::IGF DCP COMMUNICATIONS SUPPORT

Maintenance and support for the Division of Cancer Prevention (DCP) primary website and other websites, including the NCI Community Oncology Program website, the Alliance for Glycobiology website, and the Cancer Prevention Fellowship website.